Understanding and mitigating exacerbated nicotine use resulting from Pavlovianinteroceptive conditioning

PROJECT ABSTRACT
Nicotine is the primary addictive constituent in tobacco. For an individual, chronic tobacco use is associated with
a significant increase in heart disease and many forms of cancer. Increasingly, researchers are documenting
health issues associated with vaping flavored e-juice containing nicotine. There are some important sex
differences in chronic nicotine use and its health consequences. Women on average are impacted more by
environmental and sociocultural factors, take less time to become nicotine dependent, make fewer attempts to
quit, abstain for less time, relapse at higher rates, and benefit less from nicotine replacement therapy. Enormous
gains to the individual and society would come from a more complete understanding of factors that contribute
to nicotine use and misuse. Through Pavlovian conditioning processes, environmental stimuli associated with
drugs such as nicotine can become powerful modulators of drug-seeking behavior. Another related and
important factor in the development of chronic nicotine use is the pharmacological effects of nicotine serving as
an internal (interoceptive) stimulus that enters into a conditioned association with other reinforcers (e.g., peer
acceptance, alcohol, work breaks, stress relief, etc.). Thus, smokers/vapers over time develop a rich interoceptive
conditioning history with the stimulus effects of nicotine. Our long-term objective is to understand how this
conditioning history alters the trajectory of use and misuse in individuals and, in doing so, provide new clues on
how to improve cessation programs. To this end, we recently developed an innovative new approach using rats
that merges interoceptive conditioning of intravenous (IV) nicotine with its later self-administration. When IV
nicotine is repeatedly paired with an appetitive reinforcer (i.e., sucrose), this conditioning history dose- and sex-
dependently increases nicotine self-administration (21 to 126%)—an effect more profound in female rats.
Leveraging the methodological strengths of this new approach, we address three Aims in the present proposal.
Aim 1 will assess whether the need to recall the learning after a retention interval alters the strength of the
conditioned reinforcing effects of nicotine. Aim 2 will determine whether the addition of a weak reinforcer during
self-administration interacts with nicotine and its newly acquired conditioned reinforcing effects. Aim 3 will
examine whether an external (exteroceptive) stimulus will compete with the interoceptive nicotine stimulus for
conditioned reinforcing value, thus weakening its later impact on nicotine intake. A fundamental understanding
of such factors that influence the effect of interoceptive conditioning with nicotine will refine and advance our
theoretical models. These advancements will provide foundational research for other basic scientists and clues
for clinical scientists and healthcare providers working to improve approaches to treating nicotine use disorder.

Public health relevance
PROJECT NARRATIVE Nicotine use and misuse from smoking combustible tobacco reflects a major health problem with an estimated annual economic cost around $400 billion; some of the vulnerabilities and health consequences are greater in women. The potential individual and societal benefits that would come from a better understanding of factors contributing to chronic tobacco use are enormous. This benefit drives the long-term goal of our research program to understand how nicotine accrues additional reinforcing value through conditioning processes, identify factors that exacerbate or blunt the enhanced nicotine use caused by this conditioning history, and determine the role of sex as a biological variable.